Role of B-arrestins in bladder cancer progression and response to chemotherapy

Bladder cancer is the most expensive cancer to treat. Frequent recurrence and treatment refractoriness are the
most common causes of morbidity and high cost of treatment of this disease. Males are three times more likely
to develop bladder cancer. Therefore, the United States Veterans are at higher risk of developing bladder
cancer. The high-grade, muscle invasive bladder cancers are difficult to treat and neoadjuvant and adjuvant
chemotherapies have only modest benefits for overall survival. The investigators identified a pair of molecular
markers that potentially determine response to chemotherapy, especially towards the Gemcitabine + Cisplatin
chemotherapy combination. The markers β-Arrestin 1 (BARR1) and β-Arrestin 2 (BARR2) are members of the
intracellular signaling complex triggered by chemokine receptors. The research group investigated muscle
invasive bladder cancer tissues and found that BARR1 and BARR2 expressions are associated with treatment
failure and metastasis. Further, in vitro studies using established bladder cancer cell lines showed an inverse
correlation between BARR2 levels and the cancer stem cell phenotype, metastatic potential, and resistance to
Gemcitabine induced cytotoxicity. Conversely, BARR1 expression correlated with metastasis and cancer stem
cell properties. The principal hypothesis of this project is BARR1 and BARR2 are regulators of BC cell growth,
differentiation into basal or luminal cell phenotype, and BC cell motility. BARR1 and BARR2 regulate malignant
progressions, such as muscle invasion, metastasis, and resistance to chemotherapy drugs. Three specific
aims are proposed: 1. To investigate the mechanism by which BARR1 and BARR2 regulate BC growth, cancer
stem cell phenotype, and invasive/metastatic potential; 2. To investigate whether modulation of the levels of
BARR1 and BARR2 alters the response to Gem treatment in preclinical BC models. Also, test the potential of
tetrahydrouridine, an inhibitor of intracellular Gemcitabine metabolism, to sensitize chemotherapy-resistant
Patient-derived bladder tumor xenografts (PDX) towards Gemcitabine; 3. To investigate the potential of
BARR1 and BARR2 expression as a predictor of chemotherapy response and clinical outcome in MIBC. The
investigators consider the high impact of this project on improving the prediction of treatment-response in high-
grade bladder cancers as well as therapy response using a combination of a non-toxic drug and an established
chemotherapy drug. The proposed studies have the potential to improve bladder cancer treatment and
outcome for U.S. Veterans.

Public health relevance
This project is to investigate the function of two cellular signal transducing proteins, β-Arrestin 1 and β-Arrestin 2 in bladder cancer aggressiveness, cancer stem cells and develop a strong prognostic biomarker for identifying chemotherapy responsive muscle invasive bladder cancers. The project will also elucidate the potential functions of these two proteins in controlling treatment refractory cancer stem cells and the potential use of Gemcitabine cytotoxicity enhancer tetrahydrouridine to enhance response to gemcitabine treatment in bladder cancer.